Using Real Time Mobile Health Approaches to Understand and Promote Oral Chemotherapy Adherence in Adolescents and young Adults with Leukemia

PROJECT SUMMARY AND ABSTRACT
Stagnant survival and relapse rates for adolescents and young adults (AYA) with cancer are partially attributed
to a modifiable health behavior—suboptimal cancer treatment adherence. Yet, effective interventions are lacking.
Aligned with priorities of the NCI and other federal agencies, the long-term objective of this K08 application is to
help resolve disparities in cancer treatment outcomes in AYA by targeting nonadherence to life-saving cancer
treatments. The goal of this proposal is to employ novel real time mobile health methodologies to examine and
intervene on the time-varying, contextual factors that influence AYA adherence to an oral chemotherapy called
6-mercaptopurine, which must be taken daily in the maintenance phase to prevent relapse. In Aim 1, the PI and
her mentorship team will determine the temporal associations between time-varying contextual factors (such as
fatigue, motivation) and daily 6-mercaptopurine adherence. This Aim will utilize a 6-month intensive longitudinal
design that employs bursts of mobile-based ecological momentary assessment with AYA patients and their
caregivers (n=30 pairs). In Aim 2, the investigative team will begin to develop a just-in-time adaptive mobile
intervention, designed to promote 6-mercaptopurine adherence in this population, by developing contextually-
tailored mobile messages and decision rules about the conditions under which to deliver the messages. Just-in-
time mobile interventions are well-suited to address limitations of previous interventions by providing
personalized adherence support, at the right time, only when it is needed. The creation of messages and decision
rules will follow a rigorous mobile health development approach by iteratively incorporating self-management
theory, empirical evidence, expert input, and stakeholder feedback. Focus groups with 15 AYA from Aim 1 will
be conducted to user-test and refine the messages. In Aim 3, the just-in-time adaptive mobile intervention called
ADAPTS (Adherence Assessments and Personalized Timely Support) will be pilot tested in a micro-randomized
trial with 30 newly recruited patients and their caregivers. ADAPTS will integrate the tailored mobile messages
and decision rules developed and refined in Aim 2. The research team will determine the feasibility and
acceptability of this intervention in preparation for the PI’s larger-scale optimization trial (R01 proposal). This
proposal has methodological, theoretical, clinical, and technological innovations. The research and career
development plan, supported by a multi-disciplinary team of experts in a rich academic environment, will support
the PI’s transition to an independent clinician-scientist who possesses the skills and expertise to use cutting-
edge mobile health methods to design the most potent adherence- promotion interventions for pediatric cancer
patients. This K08 will provide opportunities to acquire skills and knowledge in: 1) ecological momentary
assessment and multi-level statistics; 2) behavior change intervention development applied to mobile health,
and; 3) the conduct of clinical trials and intervention dissemination and implementation.

Public health relevance
PROJECT NARRATIVE Stagnant survival and relapse rates for adolescents and young adults with cancer are partially attributed to a modifiable behavior—nonadherence to cancer treatments. To address multiple calls from the NCI and other federal agencies for research targeting disparities in cancer treatment outcomes for this population, this K08 research will use novel real time mobile health methodologies to examine and intervene on the time-varying, contextual factors that influence daily oral chemotherapy adherence in adolescents and young adults with acute lymphoblastic leukemia. The proposed research and career development plan will yield critical multi-level data and a just-in-time adaptive intervention for nonadherence, with the potential for the investigator to advance adherence intervention science and improve clinical outcomes in adolescents and young adults with cancer.